Functional Validation of Novel Variants Associated with Congenital Diaphragmatic Hernia

PROJECT SUMMARY/ABSTRACT
Congenital Diaphragmatic Hernia (CDH) is a common and severe structural birth defect arising in 1 out of 3000
live births, accounting for 8% of all congenital anomalies and 1-2% of infant mortality. The high mortality rates
are due to the abnormal lung hypoplasia and pulmonary hypertension that accompanies the herniation of the
diaphragm muscle. The genetic etiology of CDH is highly heterogeneous and our understanding of the anomaly
is incomplete. Although whole exome and whole genome sequencing has identified more than 100 candidate
genes, only ~25 have been validated with reproducibility, and we estimate that many additional CDH genes and
alleles are yet to be discovered. Animal model validation of these discoveries are often lacking, which is due, in
part, to the fact that the diaphragm is a mammalian-specific structure. The generation and characterization of
germline mouse models is costly and time-consuming, and therefore typically incompatible with the need to
screen many candidate genes and variants. The high efficiency of CRISPR/Cas9 genome editing, and the
appearance of phenotypes in founder animals has allowed us to develop a platform that can reduce the time for
validation from more than one year, to 2-3 months. The overarching goal of this proposal is to identify novel
genes and variants that are associated with human CDH and to validate these discoveries in the mouse. We will
use genome data from our large, well-characterized and longitudinally studied CDH cohort to identify novel genes
and variants in patients with CDH, and prioritize these genes and variants for validation in mouse models. We
will screen prioritized variants using our high-throughput mouse F0 platform and select a subset of hits for
germline modeling and more extensive characterization. Together, these studies will advance our understanding
of the genetics and mechanisms underlying CDH, improve diagnostic tools for patients, and pave the way for
the future development of therapeutics aimed at improving lung maturation and function.

Public health relevance
PROJECT NARRATIVE The overall goal of this proposal is to identify and validate novel genes and variants that cause congenital diaphragmatic hernia (CDH), a common and severe birth defect that is poorly understood. We will use genomic data from our large, well-characterized CDH patient cohort to identify novel genes and variants associated with CDH, and prioritize these genes and variants for validation in mouse models. Using advanced genome editing approaches, we will validate candidate variants and study promising hits in depth, providing insight into the genetics and mechanisms that underly CDH pathology.